University of Michigan Rogel Cancer Center Support Grant 2023-2028

PROJECT SUMMARY/ABSTRACT (OVERALL)
The University of Michigan (U-M) Rogel Cancer Center (Rogel) has a distinguished history of scientific
excellence, collaboration, and impact. Rogel’s Mission is to reduce the burden of cancer and advance health
equity through transdisciplinary collaboration in research, education, patient care and community outreach, and
the Vision is to be a leader in prevention, early diagnosis, optimal treatment and care for all at risk of, or affected
by, cancer. Founded in 1986 as the U-M matrix cancer center, the Center first received National Cancer Institute
(NCI) designation in 1988, and it has been a comprehensive cancer center since 1991. With strong support from
the U-M leadership team and the cancer center community, Eric Fearon, MD, PhD, was appointed as the third
Center Director in September 2016. Fearon has held multiple leadership roles in the cancer center throughout
the past two decades, including Deputy Director, AD for Basic Sciences, and Program Leader for Cancer
Genetics. The Center provides an organizational framework to promote transdisciplinary cancer research
through the development of well-funded basic, translational, clinical, and prevention programs and the
development of shared resources. The Cancer Center’s six Research Programs includes three basic programs
– Signaling and Tumor Microenvironment, Cancer Genetics, and Developmental Therapeutics; one
basic/clinical/translational program – Cancer Hematopoiesis and Immunology; one clinical/translational program
– Translational and Clinical Research; and Cancer Control and Population Science. Rogel supports 13 Shared
Resources and two developing Shared Resources: Cancer Data Science; Cell and Tissue Imaging; Experimental
Irradiation; Flow Cytometry; Health Communications; Immune Monitoring; Pharmacokinetics; Preclinical
Molecular Imaging; Structure and Drug Screening; Tissue and Molecular Pathology; Transgenic Animal Models;
Proteomics; Single Cell Spatial Analysis; Epigenetics and Epigenomics (developing); and Liquid Biopsy
(developing). The Center has 326 members representing 54 departments and nine schools and colleges across
the University of Michigan. The Rogel Cancer Center was ranked in sixth in NCI-funded academic institutions in
2021 and cancer center members have annual direct cancer-relevant funding of $105 million. The scientific
impact of the Center’s research is reflected through the 4,636 member publications during the 2017-2021 period,
including 25% of manuscripts published in journals with impact factor >10, and the strong portfolio of cancer-
focused grants held by our members. Fostering transdisciplinary collaboration is a key tenet of the Rogel Cancer
Center, evidenced by a high degree of collaborative publications (33%) and inter-institutional (47.1%) The
Medical School has made substantial commitments to the cancer center through space, financial support, and
the recognition of cancer programs as a top priority for the institution.

Public health relevance
NARRATIVE (OVERALL) The University of Michigan Rogel Cancer Center (Rogel) is committed to reducing cancer burden and improving cancer outcomes through research, innovation, transdisciplinary collaboration, education, and outreach. The Rogel vision is to be a leader in prevention, early diagnosis, optimal treatment and care for all at risk of or affected by cancer.